Cognitive Behavioral Therapy for Treatment-Seeking to Improve Treatment Engagement and Reduce Suicide Risk Among Deaf Individuals

ABSTRACT
Deaf individuals are one of the most understudied and underserved cultural populations in the field of mental
health. While limited, data suggests significant mental health disparities among Deaf adults including higher
rates of suicidal thoughts and behaviors; yet, they have low rates of mental health treatment engagement. The
Candidate’s long-term goal is to develop and test evidence-based interventions for Deaf adults to promote
mental health and reduce suicide risk. Reaching that goal requires mentored training in three domains of
clinical research, and completion of a research project to produce foundational results (described below).
First, the candidate needs to gain expertise in the design, execution, and analysis of randomized controlled
trials (RCT) with Deaf individuals (Objective 1) to successfully conduct RCTs in a reliable, valid, and ethical
manner, and test target engagement with an experimental therapeutics approach. Second, the candidate
needs to gain knowledge and skills related to research with subjects at elevated risk for suicide (Objective 2)
to safely and effectively conduct suicide prevention and treatment research. Third, the candidate needs to gain
knowledge and skills to support ease of implementation of her interventions in varied contexts including
deployment-ready and principle-driven intervention development, and implementation science (Objective 3).
The principal objectives of the proposed research study are to use deployment-ready intervention development
and implementation science methods to develop an interventionist training and monitoring program for
Cognitive Behavioral Therapy for Treatment-Seeking for Deaf individuals (Deaf CBT-TS; Aim 1), and conduct
an RCT using an experimental therapeutics approach to examine whether the intervention can modify beliefs
about treatment (intervention principles) and increase treatment-seeking behaviors (target mechanism; Aim 2).
Secondary objectives include exploring the intervention’s potential to increase hope and reduce indicators of
suicide risk (mental health symptoms, alcohol use, suicide ideation; Aim 3), and identifying factors that may
impact the efficacy of Deaf CBT-TS including acculturative stress and the availability of Deaf-accessible
treatment resources to understand factors that may impact the implementation of the intervention in varied
health service settings (Aim 4). One hundred Deaf sign language using adults with clinically significant
symptoms of depression, anxiety, PTSD, insomnia, alcohol use disorder, and/or suicide ideation (oversample
50%), who are not engaged in treatment will be randomized to Deaf CBT-TS (2 sessions) or a waitlist control
group. Half of the subjects will be from Rochester (Deaf-specialty treatment resources) and half will be from
across the U.S. Subjects will complete baseline, 2- and 4-month follow-up assessments.
Results of this K23 project will function as a basis for a larger R01 of a fully powered RCT examining clinical
outcomes (i.e., reductions in indicators of suicide risk) and the mediation effect of treatment engagement.

Public health relevance
PROJECT NARRATIVE The U.S. Deaf cultural community is one of the most understudied and underserved populations in the field of mental health despite data suggesting mental health disparities and higher rates of suicidal thoughts and behaviors among Deaf adults. Deaf individuals have low rates of mental health treatment engagement, and interventions are needed to increase treatment-seeking to reduce Deaf mental health disparities and suicide risk. This proposal forms the basis of a program of research focused on mental health treatment and suicide prevention for culturally Deaf adults in the U.S.